Illuminating the path(ophysiology) to development of youth-onset type 2 diabetes (PATH-NC)

ABSTRACT
Estimates suggest that across a period of just 16 years (2001-2017), prevalence of T2D in youth has doubled,
from an estimated prevalence of 0.34 per 1000 youths to 0.67 per 1000 youths. Through our work on the
SEARCH for Diabetes in Youth Study (SEARCH) we have reported that the incidence of T2D is
disproportionately experienced in marginalized racial and ethnic minority groups, with American Indian and
non-Hispanic Black youth experiencing the greatest burden of T2D. We have demonstrated that the well-
known complications and comorbidities of adult-onset T2D, including diabetic nephropathy, retinopathy,
peripheral neuropathy, arterial stiffness, and hypertension, have an accelerated onset in youth onset T2D.
While it has been well-established that overweight and obesity, together with family history, are associated with
increased risk for development of youth onset T2D, the majority of youth with these risk factors do not develop
T2D. T2D rarely occurs prior to the onset of puberty and it is well-established that puberty is associated with a
decrease in insulin sensitivity, with nadir experienced typically at Tanner Stage III, before returning to pre-
pubertal levels by Tanner Stage V in the healthy adolescent. Youth appear to be at greatest risk for
development of T2D as they progress toward the latter stages of puberty. We propose a longitudinal cohort
study designed to provide deep phenotyping of pathophysiologic markers across the pubertal transition for
high-risk youth with obesity, assessing these factors in relation to underexplored social, behavioral, and early
life risk factors for development of T2D in youth. As one of many clinical sites supporting this Consortium, we
are prepared to enroll 504 youth, from a highly diverse population of youth with obesity and in early to mid-
puberty (Tanner Stage II or III). Operational aims include recruiting and retaining a diverse cohort of at-risk
youth (OA1), sustaining stakeholder engagement to inform the study throughout study planning,
implementation, and dissemination (OA2), and establishing a biobank of participant specimens and samples
from which future ancillary studies can be conducted (OA3). The Scientific Aims supported by these
Operational Aims address the overarching objectives of conducting deep phenotypic characterization of youth-
onset T2D, including assessment of physiologic markers across the pubertal transition (SA 1.), establishing
social and behavioral risk factors for and protective factors against development of youth onset T2D, beyond
that which has already been established (SA 2.), and evaluating genetic and epigenetic data to further
mechanistic understanding of disease pathogenesis in youth (SA 3.). Ultimately, this work will support
increased understanding of which individuals are at risk for developing youth-onset T2D and allow identification
of determinants of progression from prediabetes to T2D, which will support groundbreaking future prevention
approaches that, once evaluated, could be tailored to individual risk.

Public health relevance
NARRATIVE Youth-onset type 2 diabetes (T2D) is associated with a more severe disease phenotype, with reduced responsiveness to adult-onset T2D treatment approaches and increased risk of earlier onset disease- associated complications. Identifying pathophysiologic factors associated with the development of youth-onset T2D is critical to identifying opportunities for disease prevention. This study includes operational and scientific aims designed to support recruitment and retention of youth at high risk of developing T2D, in support of a common protocol for a Consortium-based, multisite longitudinal cohort study of youth-onset T2D.